The Role of Gasdermin-D/Interleukin-1 Nexus in Atrial Arrhythmogenesis

PROJECT SUMMARY
Atrial fibrillation (AF) is the most frequent arrhythmia. Enhanced activation of ‘NACHT, LRR and PYD domains-
containing protein 3’ (NLRP3) inflammasome plays a causal role in promoting proarrhythmic events associated
with AF development. Activation of NLRP3 inflammasome produces two major effectors: interleukin (IL)-1b and
cleaved (active) N-terminal gasdermin-D (GSDMDNT). Results from parent grant suggest that that GSDMD could
promote atrial arrhythmogenesis by previously unrecognized pyroptosis-independent alternative functions in
cardiomyocytes and the membrane-repair machinery via ESCRT III may prevent excessive cell death upon
inflammasome activation during AF development. In this application, we will elucidate the alternative function of
GSDMDNT and the involvement of ESCRT III-mediated membrane repair machinery in cardiomyocytes.

Public health relevance
Project Narrative Atrial fibrillation, the most prevalence arrhythmia, is a public health burden. The proposed work will elucidate the function of ESCRT-mediated membrane repair in relation to gasdermin-D activation in cardiomyocytes.